M4: Modules on advanced Methodology when Modeling Multinational data

Project Summary/Abstract
The prevalence of Alzheimer's disease and AD-Related Dementias (AD/ADRD) is increasing globally,
highlighting an urgent need to identify factors influencing healthy aging and cognitive change. The Health and
Retirement Study (HRS) and its sub-study—the Harmonized Cognitive Assessment Protocol (HCAP)—together
with their international sister studies, provide invaluable resources for exploring the epidemiology of AD/ADRD.
However, there are methodological hurdles and challenges that create barriers for newer researchers to engage
with these rich data in a meaningful way. These challenges include issues related to data quality, varying cultural
contexts, and harmonizing analyses across datasets. To equip the next generation of researchers with the
necessary methodological skills, we proposed to develop M4: Modules on advanced Methodology when
Modeling Multinational data. Required modules will focus on the responsible conduct of secondary data analysis,
social and behavioral factors related to AD/ADRD, and reproducibility and open science principles. Trainees will
choose one or more optional advanced methodology modules appropriate for multinational analyses: item
response theory (IRT), coordinated data analyses (CDA), or latent variable alignment methods. Each module
will be taught across multiple sessions, allowing for didactic and hands-on training. We have four specific aims:
Aim 1: Develop and refine a module-based training program in large-scale data analysis. This is a
necessary initial step to create the modules, leveraging and adapting our existing training and tutorials. Aim 2:
Instruct trainees in protective behavioral and social factors aimed at reducing AD/ADRD in cross-
national contexts. While many different research questions could be addressed with the HRS and HCAP, a
primary intention of the proposed training is to address AD/ADRD. Aim 3: Build open science resources to
support the identification of factors affecting the trajectory of healthy aging and AD/ADRD. We believe in
open science as a primary way to expand knowledge and ensure reproducibility across projects, especially when
using widely-available data like HRS and HCAP. Aim 4: Provide ongoing mentorship in advance
methodologies. By engaging trainees across modules, we can develop mentoring relationships whereby we
can provide ongoing support in their mastery of these advanced methodologies. M4 will be offered primarily by
synchronous virtual learning. Then it will be adapted for asynchronous self-paced learning, allowing participants
to engage with it at their convenience. This is of vital importance, insofar as these are multinational data, and
international researchers need to be equipped to analyze their own data. Finally, abbreviated versions of the
modules will be offered as in-person pre-conference workshops to raise interest and enhance trainee
recruitment, ultimately aiming to foster a robust community of researchers dedicated to advancing the
understanding and reduction of AD/ADRD.

Public health relevance
Project Narrative The prevalence of Alzheimer's disease and AD-Related Dementias (AD/ADRD) is increasing globally, highlighting an urgent need to identify factors influencing healthy aging and cognitive change. The Health and Retirement Study (HRS) and the Harmonized Cognitive Assessment Protocol (HCAP) serve as key resources for understanding AD/ADRD epidemiology, but secondary analysis of these datasets presents challenges: data quality challenges, cultural context differences, and the need for advanced methodology are primary concerns. To address these issues, we proposed to develop M4: Modules on advanced Methodology when Modeling Multinational data to equip trainees around the world with skills in advanced methodology and open science methods needed to meet these complex challenges.